Pierce Food Program Standards Initiative

Pierce Food Program Standards Initiative Project Abstract The Pierce Food Program Standards Initiative will reduce the incidence of foodborne illness by increasing Pierce County Washington’s compliance with the FDA food code. Progress will be made on each of the FDA Retail Program Standards with the goal of gaining compliance with seven out of nine standards by 2020. Increased conformance with the Program Standards will: • Enhance program uniformity • Focus on program areas that have the greatest food safety impact • Cultivate wide spread effective risked-based intervention strategies • Provide guidance in program implementation and administration • Improve communication among stakeholders on how to best reduce foodborne illness • Improve industry and consumer confidence in our food safety program The Tacoma-Pierce County Health Department will lead this initiative and use grant funds to support project staffing, conduct a risk factor assessment, implement project plans, develop systems and policies and increase educational and community engagement efforts. A large focus of this initiative is using Quality Improvement tools and processes to develop and improve systems with a focus on continual improvement and sustainability, so that successes will carry on beyond the life of the grant period. Health Department Quality Improvement Coordinators will provide ongoing assistance in this area. Using the Food Programs Communication, Community Engagement and Customer Service Plan, stakeholders will have a greater level of involvement in food safety issues within the county. Educational and outreach strategies will be used to increase understanding of food safety, improve compliance with the Pierce County food code and engage communities in decision making. Successes and lessons learned will be shared with the FDA, local, national and other partners to help forward innovations and gains in this area to create a healthier food supply. Pierce Food Program Standards Initiative Project Abstract

Public health relevance
Pierce Food Program Standards Initiative Project Narrative The Health Department is applying for this grant opportunity to develop a more effective and well- rounded food safety program. The Pierce Food Program Standards Initiative will help prevent illness in our community through food safety assessment, systems changes and policy development. We will use FDA Food Regulatory Program Standards as a framework for building a plan, Quality Improvement (QI) tools to monitor progress and measure success, and effective sustainability practices to ensure that our successes continue beyond the life of the grant. Pierce Food Program Standards Initiative Project Narrative